REGULATION OF PHYSIOLOGY DURING AGING VI--NEURONAL DEGENERATION AND PLASTICITY

This research project is directed to understanding molecular mechanisms of age-related neurodegenerative diseases. Emphasis is placed on markers of synaptic loss and neuronal plasticity.